Parietal Cortex Networks for Sensorimotor Processing During Navigation

Project Summary
Spatial navigation is essential for the survival of most animals. It requires an understanding of the spatial
relationships within an environment and the ability to make decisions about goal locations and how to reach
those locations. In our previous grant period, we discovered a multi-area cortical network, with dense inter-
communication, that is critical for the decision-making and planning functions in navigation. Our findings revealed
that a central component of this network is the posterior parietal cortex (PPC), which is essential for behaviors
requiring navigation decisions and has activity at the interface of sensation and action. Despite our work revealing
the importance of PPC and a long literature studying the role of PPC in decision-making, remarkably little is
known about the mechanisms by which PPC performs its computations, including the connectivity motifs it
contains, how these connectivity motifs relate to its function, if and how molecular cell types contribute in distinct
ways, and what plasticity programs control its changes over learning. These topics have not been addressed in
depth largely because of a lack of tools to provide detailed mechanistic investigation in the context of cognitive
behaviors like those for navigational decision-making. Here, we propose to build and use a toolset to study the
connectivity, cell types, and plasticity pathways in PPC to discover the mechanisms underlying PPC’s
contribution to navigational decision-making. In a first aim, we will use cellular resolution optogenetics to map
the effective connectivity between functionally characterized neurons in PPC during a navigation decision task
in virtual reality. We will test for connectivity motifs proposed by theoretical models of decision-making and
information propagation. In a second aim, we will study the activity patterns and connectivity motifs of inhibitory
neurons in PPC and test their causal roles in computations related to navigational decision-making. In a third
aim, we will investigate the molecular plasticity mechanisms that are activated during navigational learning and
that give rise to the activity patterns in PPC. We will study how these plasticity mechanisms reorganize the
connectivity within the circuit. Together, the proposed research will be some of the first to understand PPC and
decision-making at a detailed mechanistic level of connectivity motifs, cell types, and plasticity programs.
Furthermore, we anticipate that the findings and approaches will be of interest for understanding mechanisms of
cognitive function more generally.

Public health relevance
Project Narrative The proposed research studies spatial navigation and decision-making, which are core components of cognitive function and are disrupted in neurodegenerative disorders, including Alzheimer’s disease. The proposed experiments will develop new tools to understand the neurobiology of these processes at the level of connections between neurons and cell types, toward forming a foundation for understanding how these processes malfunction in neurological disorders.